Administration of Comprehensive Assessment of Occupationally-Relevant Exposures

NIOSH scientists participate in review and oversight of National Toxicology Program (NTP) activities including a number of interagency agreements and reviews of NTP research and reports. This task order provides financial support to NIOSH personnel to travel to, attend, and participate in several NTP meetings held in Research Triangle Park, NC and Washington, DC. These included Interagency Committee for Chemical Evaluation and Coordination meetings, NTP Technical Report meetings, NTP Board of Scientific Counselors meetings, Report on Carcinogen meetings, NTP Executive Committee Meetings, and ad hoc meetings addressing specific NTP issues. All of these meetings are held to investigate, define, or report hazards associated exposure to environmental chemicals. Many of the exposures are occupational and NIOSH personnel provide expert opinion on chemical exposures linked to cancer, respiratory disease, development and reproductive disorders, neurotoxicity, and immunological toxicity.